Yale Post-Baccalaureate Research Education Program

Project Summary
This proposal describes a Post-Baccalaureate Research Education Program (PREP) at Yale University that
will provide seven (7) underrepresented (UR) participants with a one-year program of evidence-informed
faculty and near-peer effective mentored research training and technical, operational, and professional skills
development for entry into rigorous biomedical, research-focused Ph.D. or M.D./Ph.D. programs. Participants
will serve as research post-baccalaureates at nine person-months (75% full-time) effort and three person-
months (25% full-time) effort to further skills development. The long-term goal of the proposed PREP is to
expand the pool of well-trained, diverse biomedical scientists with the range of perspectives needed to address
important problems in human health and disease, including health disparities.
The proposed Yale PREP will recruit baccalaureate graduates from a wide range of colleges and universities
but especially Historically Black Colleges and Universities (HBCUs) and Hispanic Serving Institutions (HSIs)
through established partnerships. The Yale PREP will also leverage its long-standing, 28-year relationship,
with the Leadership Alliance to recruit and mentor participants.
Specific measurable PREP participant objectives include: (1) Increased level of preparedness for applying to
Ph.D. or M.D./Ph.D. programs; (2) Increased knowledge and understanding across biomedical disciplines; (3)
Increased understanding of scientific reasoning, rigorous research design, experimental methods, and
quantitative and computational approaches; (4) Increased understanding of what it means to approach and
conduct research responsibly, ethically, and with integrity; (5) Experience initiating, conducting, analyzing,
interpreting, and presenting reproducible research with increasing self-direction; (6) Development of skills to
communicate scientific research methodologies and findings to a wide variety of audiences in writing and
verbally; (7) Increased health disparities knowledge; (8) Increased knowledge of the varied career paths in
biomedical research. Expected outcomes include: (1) Having greater than 75% of participants transition into
rigorous research-focused Ph.D. or M.D./Ph.D. programs in biomedical fields within two years of completing
the PREP; (2) Having Ph.D. and M.D./Ph.D. completion rates of former PREP participants that are comparable
to or greater than students in similar disciplines at their institution; and (3) Having former PREP participants
enter careers in the biomedical research workforce.

Public health relevance
Project Narrative Yale University proposes to establish a Post-Baccalaureate Research Education Program (PREP) that develops a diverse pool of well-trained post-baccalaureate participants. With evidence-informed faculty and near-peer effective mentored research training and appropriate technical, operational, and professional skills development, these researchers will transition into and complete rigorous research-focused Ph.D. or M.D./Ph.D. programs in biomedical fields. The long-term goal is to expand the pool of well-trained, diverse biomedical scientists with the range of perspectives needed to address important problems in human health and disease, including health disparities.